Lysosome dysfunction in podocytopathy and associated hypertension

Project Summary
Podocytopathy is an important pathogenic basis for different glomerular diseases such as minimal change
disease (MCD), diffuse mesangial sclerosis, focal segmental glomerulosclerosis, collapsing glomeru-
lonephropathy and global glomerulosclerosis associated with hyperhomocysteinemia (hHcy), obesity and
diabetes mellitus. These glomerular diseases have been reported to account for the vast majority of end-stage
renal disease and kidney-associated hypertension and cardiovascular diseases. Recent studies have indicated
that normal autophagy is a critical cellular process to control podocyte function and even its life span and that
deficient autophagy and associated autophagosome (AP) accumulation or increases in exosome release
produce podocyte injury and podocytopathy. We have shown that a sphingolipid-mediated signaling pathway is
importantly implicated in lysosome dysfunction, autophagic flux deficiency and ultimate podocytopathy and
glomerular sclerosis. The present grant proposal will test a central hypothesis that lysosomal acid ceramidase
(AC)-mediated sphingolipid metabolism critically controls lysosome trafficking or fusion to APs or multivesicular
body (MVB) and subsequent degradation process determining the normal phenotype and function of
podocytes. AC gene defect or functional deficiency may disturb lysosome degradation of APs and MVBs,
which induces AP accumulation and exosome release from MVBs leading to podocyte phenotypic transition,
effacement and ultimate MCD. To test this hypothesis, three Specific Aims are proposed. Specific Aim 1 will
determine whether autophagic flux and exosome excretion in podocytes are fine controlled by lysosomal AC
activity and whether the deficiency of this AC regulation causes podocytopathy and MCD in Asah1fl/fl/Podocre
mice, but not in their littermates. Specific Aim 2 attempts to elucidate the central role of lysosomal AC-
mediated sphingolipid signaling in the regulation of lysosome trafficking to and fusion with APs and MVBs for
their degradation using podocyte-specific Asah1 gene deletion, rescuing and silencing. In Specific Aim 3, we
will explore the mechanisms by which lysosome trafficking or fusion in podocytes is regulated by AC-
associated sphingolipids via gating lysosomal TRPML1 channels and associated Ca2+ release using patch
clamping of isolated lysosomes and lysosome-specific Ca2+ imaging with GCaMP3-ML as an indicator. These
proposed studies will present a novel mouse model for podocytopathy and MCD and use this model to explore
associated molecular mechanisms triggering podocytopathy. The grant proposal represents the first effort in
the research field to investigate the AC-mediated lysosome regulation of autophagic flux and exosome
excretion in podocytes and associated pathogenic role in potocytopathy. The findings may make paradigm shift
in understanding pathogenesis of podocytopathy and MCD and help identify lysosomal AC as a therapeutic
target for prevention or treatment of MCD and other glomerular diseases.

Public health relevance
Project Narrative The podocyte, a highly specialized cell type with a unique structure in the kidney, determines renal function, preventing protein leakage into urine that may cause end-stage renal disease and various complications. This grant application seeks to explore the molecular mechanisms by which podocyte function is controlled via a novel lipid signaling pathway within this type of cell. It is anticipated that the findings from the proposed studies will increase our understanding of the molecular mechanisms responsible for podocyte injury and thereby help identify therapeutic targets for prevention or treatment of end-stage renal disease and associated heart and blood vessel complications.